siRNA-based Gold Nanoparticles as a Therapeutic Enhancer for Triple Negative Breast Cancer (TNBC) Radiotherapy

ABSTRACT
Radiation therapy (RT) modulates immunological properties of tumor microenvironment (TME) to stimulate
antitumor immune response. However, RT initiates immunosuppressive mechanisms as well and therefore
diminishing the effects of RT immuno-stimulation. One of the main RT immunosuppressive modes is exerted by
an increase in TGFβ production that in breast cancers (BC) has an additive effect on already high TGFβ levels
produced by cancer cells themselves. Triple negative breast cancer (TNBC) in particular, was demonstrated to
have higher TGFβ levels compared to other BCs, and this finding correlated with increased tumor grade and
invasiveness, and a diminished patient survival. Consequently, RT induced increase in TGFβ within the TME
may further potentiate invasiveness and metastatic potential of TNBC. Due to stimulatory aspects of RT
immunomodulation, RT has gained interest as a prospective therapeutic enhancer in cancer immunotherapy,
such as immune checkpoint blockers, that has shown great potential in improving local control and overall
survival in select cancers. Unfortunately, in most forms of BC, including TNBC, response to immunotherapy
remains modest. Our long-term goal is to use RT to enhance TNBC response to immunotherapy by taking
advantage of RT immunomodulatory potential. Antitumor RT effects, including TME immunomodulation can be
improved by using radiosensitizers, such as gold nanoparticles (AuNP). Furthermore, AuNPs can also serve as
a drug delivery system by conjugation of small interfering RNAs (siRNAs). In this project we propose to use
AuNPs functionally modified by TGFβ siRNA to simultaneously enhance RT immunomodulation and counteract
the immunosuppressive effects related to the increased TGFβ production. This approach will enhance RT
antitumor effects and create a favorable TME environment for better response to future immunotherapies. This
will be tested by the following specific aims: Aim 1: To synthesize and characterize AuNP-siRNATGFβ1; Aim
2: To investigate the therapeutic effect of combination of RT and AuNP-siRNATGFβ1 in in vitro and in vivo
mouse TNBC model. The proposed studies in determining the potential of AuNPs simultaneously target
antitumor and immunomodulatory RT effects will provide critical information for improving TNBC response to
immune checkpoint blockers and for designing future RT/ immune checkpoint blockers multimodal TNBC
therapies.

Public health relevance
Project Narrative The proposed research aims to explore new approaches to stimulate antitumor immune response in triple negative breast cancer. Our study will show that the use of targeted gold nanoparticle together with radiation treatment can change the immune profile of tumor tissue into an environment promoting antitumor immune response. This work is directly relevant to public health as the findings of this study will help the design of immunotherapeutic interventions that will improve clinical outcome and survival in patients with triple negative breast cancer as well as the other cancer types.